MUSC Minority Student Development Program

[unreadable] DESCRIPTION (provided by applicant): The goals of this program are to: 1) increase the number of underrepresented minority (URM) students choosing a research career in the biomedical sciences, 2) enhance the quantity and quality of URM students enrolled in the doctoral program in the College of Graduate Studies, 3) prepare them for a successful career in biomedical sciences, 4) provide structured activities that enhance the interaction of minority and majority students and 5) increase the number of URMs in the Summer Undergraduate Research Program (SURP). To accomplish these goals a Minority Recruitment Committee will be developed to assist in recruiting URMs. An MUSC "Science Day" will be implemented to expose minority students to the excitement of biomedical science research. Undergraduate science advisors will nominate potential URM Ph.D. applicants who will attend "Science Day" with a parent and the advisor. The SURP will be expanded by five students, designated as E.E. Just Scholars. These SURP participants will interact with minority graduate students via a Big Brother/Sister program. A summer pre-matriculation course to review basic biochemical and molecular concepts will be available for all new students. All students will participate in a "Diversity in Science" course that will foster the interaction of minority and majority students that focuses on issues related to minorities in biomedical science. URM graduate students will serve as Graduate Student Ambassadors to HBCUs and present seminars to undergraduates. Funds will be provided for URM graduate students to present their research at a national meeting. A Mentoring Committee will be developed to 1) monitor and advise URM doctoral students through the graduate training program, 2) assist with career development and 3) organize the content of the "Diversity in Science" course as well as career workshops. Internal and External Advisory Committees will provide oversight for the program. These programmatic elements will increase the number of minority students participating in biomedical science research and prepare them for a successful career. [unreadable] [unreadable]